3D imaging of cells and tissues using polarized light microscopy

Project Summary
We are proposing to continue our development of polarized light microscopy techniques for analyzing the
architectural dynamics inside living cells, tissues and whole organisms. We propose to add comprehensive
polarization analysis to two multi-view imaging techniques, the dual-view plane illumination microscope, or
diSPIM, and the light-field microscope. Both types of polarized light microscopes represent significant new
developments that for the first time enable the measurement of molecular orientation parameters in three
dimensions at high spatial (0.5µm in all three dimensions) and temporal (faster than 1Hz) resolution. The
project includes the development of the hardware, software and algorithms required for capturing multi-view
image data and their tomographic reconstruction into 3-dimensional maps of birefringence and polarized
fluorescence. The instrument development is guided by several application projects including the remodeling of
the extracellular collagen matrix by fibroblast cells and the spatial coordination in the assembly of higher order
septin structures inside eukaryotic cells. Information about the technology, including software components and
instrument design that are developed under this grant, will be made available for users and developers on an
established web portal called OpenPolScope.org.

Public health relevance
Project Narrative The microscope instrumentation developed under this grant will have applications in medical research and clinical settings. The cell biological application projects that will be forthcoming under this grant will have broad implications for our understanding of cell division and cellular remodeling of tissue, which are fundamental processes in health and disease.